Alcohol-Induced End Organ Diseases Meetings

ABSTRACT
Alcohol misuse is one of the leading preventable health risks globally, contributing to over 60 different diseases
and injuries. The associated morbidity and mortality impose a significant health and economic burden on society.
Alcohol-induced end organ diseases, including alcohol-associated liver disease, cancer, pancreatitis, and others,
contribute significantly to alcohol-related morbidity and mortality. These diseases often synergize with other
epidemic diseases such as obesity, diabetes, and drug abuse. Despite advances in the field, the underlying
disease etiology of alcohol-induced end organ diseases remains poorly understood. There is an urgent need to
gain new knowledge of the molecular underpinnings to accelerate diagnosis, prevention, and treatment. This
R13 proposal seeks support for the Gordon Research Conferences (GRC) on Alcohol-Induced End Organ
Diseases in 2025 and 2027. The overarching goal of the GRC Alcohol-induced End Organ Diseases
meetings is foster open and inclusive discussion of research developments, establish new scientific
collaborations, encourage participation of diverse and underrepresented groups, and propel the next
generation of scientific advances. The GRC was initiated in 2017 and has held successful meetings in 2021
(delayed to 2022) and 2023. The open format of the GRC model allows for sharing significant unpublished work
and provides ample opportunities for in-depth discussions with peers, new colleagues, and the future generation
of alcohol researchers. The GRC on Alcohol-Induced End Organ Diseases plays a crucial role in advancing the
field by providing a platform for the dissemination of key research findings, fostering collaboration, and promoting
scientific progress. The unique format of the conference ensures ample time for in-depth discussions, enabling
the formulation of new approaches and the initiation of collaborations. By providing a safe and respectful forum
for open discussion, the conference encourages the exchange of cutting-edge research on alcohol-induced
tissue injury. The introduction of breakthrough techniques facilitates a deeper understanding of the mechanisms
underlying alcohol-induced tissue injuries, paving the way for innovative approaches to diagnosis, prevention,
and treatment. Moreover, the conference promotes interaction between junior and senior investigators, fostering
mentorship opportunities and facilitating knowledge transfer across generations. By including scientists from
disadvantaged backgrounds at all career stages, the conference ensures diverse perspectives and encourages
equitable participation in the scientific community. We envision this meeting to significantly advance our
understanding of the underlying mechanisms of end organ injuries and drive the development of effective
therapeutic strategies for the diagnosis, prevention, and treatment of alcohol use disorders, ultimately improving
health outcomes worldwide.

Public health relevance
The Gordon Research Conference (GRC) on “Alcohol-Induced End Organ Diseases” will create a state-of-the-art forum for discussion of alcohol research, including studies of acute and chronic alcohol exposure across the entire spectrum of lifespan on the significant and widespread detrimental organ system effects of alcohol. The conference will provide a unique forum to bring together alcohol researchers spanning all career stages, as well as experts in complementary fields, to discuss groundbreaking advances in how alcohol consumption results in tissue injury. The meeting format employed by the GRC facilitates open discussions, builds bridges in between investigators in different disciplines, as well as between preclinical and clinical investigators and fosters the development of the next generation of alcohol researchers.